Project 2: Mitigation of radiation toxicity in treatment of sarcoma with FLASH vs. Standard dose rates

Project Summary
Radiotherapy (RT) is used in the treatment of soft tissue sarcomas (STS), frequently in conjunction with
surgical removal of gross disease. For pre-op RT, 50 Gy equivalent in 2 Gy fractions (EQD2) is commonly used,
while post-op RT requires 60–66 Gy (EQD2). For definitive (curative with RT alone) schedules, doses from 75–
100 Gy (EQD2) are needed. Paralleling changes in the RT field, STS are being treated with increasingly
hypofractionated schedules, but the combination of high dose and/or high dose per fraction RT to larger tumor
volumes can increase normal tissue toxicity. Indeed, patients with STS who receive RT risk major bone and soft
tissue problems including skin toxicity, non-healing ulcers, necrosis, lymphedema, bone fractures and second
malignant neoplasms (SMNs). This project will test the overall hypothesis that FLASH proton radiotherapy (F-
PRT) spares normal soft tissues and bone from early/late toxicities compared with standard PRT (S-PRT),
whereas the two modalities will be isoeffective in controlling sarcoma growth. Our preliminary data show reduced
skin damage, normal tissue inflammation, lymphedema, and vascular damage with F-PRT vs S-PRT. In addition
to modeling typical side effects of RT, as a malignancy that requires high dose RT to achieve local control,
sarcoma represents a good proving ground to evaluate whether F-PRT sufficiently modulates RT therapeutic
index to be clinically useful in other cancers. In Aim 1, the ability of F-PRT to abrogate tissue effects that pose
barriers to the treatment of sarcomas with RT will be tested using the following hypotheses in in vivo mouse
models: (i) the inflammatory component of normal tissue toxicity to F-PRT will be attenuated relative to S-PRT,
leading to less severe fibrosis and lymphedema after F-PRT compared to S-PRT by reducing the production of
pivotal drivers, such as TFG-b and VEGF-C (ii) F-PRT will produce less injury to tissue vasculature and preserve
its associated matrix, providing for faster and more complete recovery of skin and bone than is feasible with S-
PRT. In Aim 2, we will assess clinical outcome in murine sarcomas treated with F-PRT. Among the long-term
survivors of mice treated with whole body irradiation, we find fewer tumors in the F-PRT-treated group than in
the group treated with S-PRT. In Aim 2.1, we will employ a mouse model with transient p53 knockdown in
conjunction with wildtype controls, to test the ability of F-PRT to reduce the incidence of SMNs compared with
S-PRT. In Aim 2.2 we will perform dose escalation studies in mice bearing sarcomas to define the therapeutic
window of F-PRT when added in the pre-op setting as either one or three fractions. In Aim 3, we will conduct a
phase 1 dose escalation study using pre-op (amputation) doses from 21-30 Gy (4 dose levels) in one fraction to
determine safety and tolerability of F-PRT and provide pathologic evidence of efficacy. For a phase 2 definitive
trial, we will determine feasibility, toxicity and efficacy of hypofractionated (3 fraction) F-PRT at a BED-matched
maximum dose level informed by the Phase I study to provide parameters for the design of future F-PRT trials
in humans with STS and other malignancies.

Public health relevance
Project Narrative Radiotherapy is generally not used to treat sarcomas in the definitive (without surgery) setting due to the significant morbidity (skin toxicity, lymphedema, second cancers, bone fractures, etc.) associated with the high doses that would be required. FLASH proton therapy, which delivers high doses within less than a second, has the potential to spare normal tissues from injury; hence, our long-term goal is to translate FLASH into the clinic for use in human patients with soft tissue sarcomas. In the context of radiotherapy for sarcoma,this project will elucidate mechanisms by which FLASH spares normal tissues through investigations in mice, and it will determine the safety and efficacy of FLASH when used for treatment of dogs with osteosarcomas.